Targeting Chemoreceptor Control of Breathing during Sleep to Mitigate Opioid-Associated Sleep Disordered Breathing

The U.S government has declared an opioid crisis in the country and federal health agencies are
adopting emergency measures to obviate the high mortality associated with prescription opioid drug use. There
is an increased risk for sleep disordered breathing (SDB), sleep-related hypoventilation and irregular breathing
in individuals on chronic prescription opioid medications. Almost 30% of a veteran sleep clinic population had
opioid-associated central sleep apnea (CSA). Gravely, in a national sample of Veterans, sleep apnea was a
significant risk factor for opioid-related toxicity and overdose and the presence of CSA combined with chronic
prescription opioid use compounded the mortality risk. There are only limited and partially effective therapies
for this sleep disorder.
Nevertheless, the exact mechanisms by which opioids produce SDB in adults remain unclear, and
varied and conflicting ventilatory control mechanisms have been suggested. Thus, we will systematically
investigate the chemoreceptor control mechanisms contributing to the increased propensity of SDB associated
with chronic prescription opioid use. We will investigate the effects of chronic opioid use on ventilatory
chemoresponsiveness and cerebrovascular responsiveness to carbon-dioxide and determine whether
modifying these mechanisms with hyperoxia or acetazolamide will mitigate opioid-related SDB/CSA. The
information garnered from the proposed experiments will drive development of novel personalized therapies to
reduce SDB associated with chronic opioids in Veterans and, ultimately, will positively impact their long-term
health and well-being.

Public health relevance
There is an opioid crisis in the U.S. with significantly increasing mortality risk associated with chronic prescription opioid medication use. Chronic prescription opioid use also increases the risk for sleep apnea and the risk for death in those with both sleep apnea and opioid medication use. However, the exact pathways by which opioids promote sleep apnea remain unknown. There are limited therapies for this disorder. Our research will elucidate the mechanisms by which chronic prescription opioids users develop sleep apnea and will also determine whether oxygen or acetazolamide will reduce or eliminate opioid-related sleep apnea via different pathways. A cumulative effect of our research will fulfil our long-term goal of using novel alternative therapies to alleviate sleep apnea and its associated life-threatening complications in Veterans.